Digital Multimedia Cervical Cancer Kiosks for Latinas

DESCRIPTION (provided by applicant): Although cervical cancer mortality rates declined by approximately 1.8 percent annually in the past decade among women in the U.S., the mortality rate for Latinas increased during this time period at a rate of 0.2 percent per year. The long-term goal of this study is to develop a cervical cancer education intervention for low-income, low literacy Latinas to address this health disparity. The specific aims of this study are to: (1) develop culturally and linguistically appropriate cervical cancer screening messages, (2) develop interactive, multimedia kiosks to deliver the education intervention, (3) evaluate the efficacy of the intervention to promote Pap screening, and (4) evaluate the acceptance of the interactive, multimedia kiosks by the target population. The multimedia kiosks will integrate emerging technologies to create next-generation digital kiosks that deliver stunning full-motion video with crisp digital images and sound in compact, mobile, reliable and cost-accessible units. Interactive multimedia digital kiosks have great potential as a cancer education platform in the $931 million health education media market. These kiosks can reach multiple population groups with a single product through custom-tailored messages at a significant price point. The study employs a randomized, pre-test and post-test, control-group experimental design. A total of 900 low-income Latinas will be accrued at one rural and two urban community clinics in California. Study participants will be randomly assigned to either an experimental or control condition in equal numbers after they are administered a pre-test. The experimental group will be exposed to a multimedia cervical cancer education intervention while the control group will receive a cervical cancer brochure, which represents standard care for cervical cancer education. Six-months from baseline, a post-test will be administered to both treatment and control groups. These data will be analyzed using chi-square tests to compare the study arms to determine behavioral and attitudinal outcomes, as well as change in self-efficacy and decisional balance. Multivariate models will be used to examine covariates of the intervention effect.